Regulation of the Native Protein Landscape by Molecular Chaperones

ABSTRACT
Cell homeostasis relies on dynamic and effective protein pathways. Typically, cooperative
interactions between partner factors drives selectivity, yet the inherent stability of such complexes can
be a detrimental to cell function. Adding to the complexity is the nature of the cell interior, which is
densely packed with biological molecules with each having multiple, potential binding partners. As
these features challenge the effectiveness of biological pathways by increasing the occurrence of off-
pathway or non-productive interactions, cell must have mechanisms to counter these challenges. We
believe molecular chaperones, in part, help resolve these complexities. Specifically, we suggest that
the Hsp90 molecular chaperone system has evolved to recognize select intrinsically disorder regions
(IDRs) on native proteins to both recognize client polypeptides and regulate their actions.
Furthermore, we believe a breakdown in the Hsp90 network results in a deterioration of numerous
cellular pathways and a triggering of premature aging.

Public health relevance
PROJECT NARRATIVE Molecular chaperones contribute to cell homeostasis by managing the biogenesis of nascent polypeptides, regulation of native proteins, and triage of damaged factors. While there is a substantial understanding on how chaperones contribute to the folding and degradation of proteins, how chaperones help govern native proteins and/or protein complexes is less well understood. We believe the Hsp90 molecular chaperone system is a key contributor to creating a dynamic and effective cellular environment for the native protein landscape.